Promoting regenerative repair of aged cartilage

PROJECT SUMMARY/ABSTRACT
Age is the number one risk factor for osteoarthritis (OA), however, the mechanisms that drive age-associated
joint changes and how these contribute to cartilage damage are not well defined. As OA joint tissues age, it is
well established that cartilage-forming stem cells (CSCs) display a significant decline in their ability to
differentiate, and the joint environment becomes more inflammatory. Both of these factors together undermine
the ability to recover from injuries and also contributes to the failure of autologous stem cell therapies. Thus, we
propose an innovative dual strategy which will address both. We hypothesize that activation of sirtuin 6 (SIRT6)
will rejuvenate older CSCs, and apoptosis signal regulating kinase 1 (ASK1) inhibition will reestablish a
regenerative environment in the joint. Together, this novel solution has the potential to greatly augment the ability
for CSC differentiation and cartilage repair in the aged population. We will test this hypothesis and determine the
epigenetic mechanisms that SIRT6 regulate in the following three Aims. In Aim 1, we will determine the
mechanisms by which (a) SIRT6 activation and (b) ASK1 inhibition enhance the cartilage-forming differentiation
and pro-survival activities of aged CSCs. In Aim 2, we will determine the efficacy of SIRT6 activation, in the
presence of ASK1 inhibition to stimulate cartilage formation in aged, male and female rodents. Finally, in Aim 3,
we will determine the efficacy of SIRT6 activation and ASK1 inhibition to promote cartilage regeneration and
repair in response to chondral injury in a pre-clinical aged minipig model. These Aims will be achieved through
comprehensive in vitro analysis of young and old (male and female) CSCs and macrophages, in proof-of-concept
aging rodent models (mice and rats), and a clinically relevant large animal chondral defect model (aged minipig).
Importantly, the findings from this proposal are likely to give unique and important insights into the role of
epigenetic regulation of aged cells and the role of the surrounding environment in other aging and diseased
tissues. If successful, the overall impact of this novel pro-regenerative therapy to ameliorate the ravages of aging
and joint injury would represent a significant advancement in the treatment of age-associated diseases, such as
OA. Additionally, it will lead to the discovery of new disease-modifying treatments for other organ systems and
increase the ability of the aged population to live a healthy, mobile life.

Public health relevance
PROJECT NARRATIVE As people age they lose the ability to heal from injuries or diseases like osteoarthritis, partially due to a reduced ability of old stem cells to differentiate and an inhospitable tissue environment that no longer supports repair. To address this, we propose to 1) activate SIRT6, a sirtuin that can epigenetically reverse age-associated changes in stem cells and 2) inhibit apoptosis signal regulating kinase 1 (ASK1), a protein associated with cell death and inflammation, in the tissue environment. We will test the ability of this novel dual strategy to enhance stem cell differentiation and promote a more regenerative tissue environment in articular cartilage defect models of aged animals.